Evaluation of Radiomic and Blood-Based Biomarkers for the Early Detection of Lung Cancer in People Living with HIV (Biospecimen/Cohort)

Project Summary/Abstract:
People living with HIV (PLWH) are living longer because of effective antiretroviral therapy (ART). With longer life
expectancy, PLWH are experiencing an increased incidence in non-AIDS defining malignancies.1 Lung cancer
is the most common cause of cancer mortality and is one of the most commonly occurring cancers in this
population. Lung cancer incidence is nearly three times higher in adults with HIV as compared to those without
HIV.2 Screening for lung cancer with low-dose CT (LDCT) reduces mortality by at least 20%.3-6 The reduction in
mortality may be even greater in PLWH, as they have been shown to have shortened survival following lung
cancer diagnosis largely due to late-stage presentation.7 Currently PLWH are subject to the same screening
eligibility criteria as those without HIV, based only on age and smoking history.8 While the prevalence of smoking
is higher among PLWH, studies that have controlled for tobacco use still showed a significant increased risk for
lung cancer among PLWH compared to adults without HIV.1 This could indicate that HIV modifies the risk for
lung cancer independent of smoking intensity and duration. PLWH who are adherent to ART and continue to
smoke are significantly more likely to die from lung cancer than from AIDS-related causes.9
The rapid advancements in machine learning with LDCT have significantly enhanced the accuracy of predicting
lung cancer incidence and mortality using medical imaging. Our latest deep learning model has achieved AUC
> 0.91 when evaluating overall cancer risk in nodules identified during screening. This assessment was
conducted using thousands of LDCT scans from both in-house sources and the National Lung Screening Trial
(NLST), encompassing data from over 20,000 patients. 10-12 Additionally, we have recently introduced fully
automated body composition analysis into lung cancer risk prediction models, which has added value for patients
as it can predict outcomes, specifically all-cause mortality.13 However, applying these models to PLWH may
not yield the same level of accuracy due to the models being trained primarily on the general population.
This discrepancy highlights the well-known issue of domain adaptation, where a model developed for one
specific population might not perform as well when applied to a different group. In response to this challenge,
our current study aims to assess the effectiveness of our previously validated AI models using real-world data
from PLWH.
Lung screening may be improved by incorporating blood-based biomarkers with imaging. There is a need for
better and more accessible biomarkers to improve lung cancer detection. Biomarkers with multi-protein panels
(MPPs) are emerging, but it is unknown if these will improve early detection or improve care. Before MPPs can
be used at scale, we need to understand the sensitivity and specificity of these biomarkers, especially in patients
who are at increased risk, for example, those living with HIV.